Antihypertensive self-titration to improve US blood pressure control

Nearly 1 in 2 US adults has hypertension, and it is a leading cause of myocardial infarction, stroke, and
death. Despite the importance of hypertension and the widespread availability of medication treatment, less
than half of patients have blood pressures that are controlled. This is in part due to the way in which we deliver
care, and new strategies are needed to achieve better blood pressure control. Team-based care with
medication titration by a non-physician is a promising approach, but the cost and infrastructure required make
this option less feasible. An alternative strategy is to have patients self-manage their own hypertension by
checking blood pressures and following an algorithm, pre-planned between the patient and primary care
doctor, to intensify their medications at home. Despite evidence for the safety, effectiveness and cost-
effectiveness of this approach, it has not yet been incorporated into routine care.
Prior to a large-scale trial of this intervention in the US, several key factors need to be tested. First, the
sociodemographic characteristics of patients with hypertension in the US, patient preferences, practice
patterns, perspectives of US providers and regulatory environment are different from the original trials. Our
preliminary work has demonstrated that US patients and providers are enthusiastic about antihypertensive self-
titration, and that adaptation of the intervention to the US context will require specific prioritization of diverse
patient participation. Moreover, usual care has evolved, and an adapted intervention will need to optimally
utilize the electronic health record and consider use of connected home blood pressure cuffs.
Thus, in this project we will complete key preparatory steps to ensure the intervention is adapted to and
implementable in the US primary care context. In Aim 1 we will refine our process to identify patients with
uncontrolled hypertension to incorporate home blood pressure measurements. In Aim 2 we will develop and
refine recruitment and intervention materials and processes based on feedback from a diverse group of
healthcare team members and patients. We will then pilot test all aspects of the intervention in clinical care for
30 patients to determine reach, adoption, feasibility and fidelity (Aim 3). Upon completion of this work all
materials and procedures will be proven ready for the successful conduct of a randomized trial testing
antihypertensive self-titration in the US primary care context.

Public health relevance
Hypertension contributes substantially to cardiovascular disease burden, yet effective control remains elusive for many individuals due to lack of intensification of medication treatment and suboptimal adherence to treatment protocols. A promising but underused approach in the US involves patients self-titrating their antihypertensive medications based on predefined protocols, which has shown potential in trials in Europe with minimal resources. To adapt this intervention to the US context, this work proposes to refine recruitment procedures and intervention materials and processes and pilot test the revised intervention to ensure feasibility, fidelity, and equity, setting the stage for a subsequent large, randomized trial to evaluate effectiveness of the approach and integration into primary care.